IMPROVING OUTCOMES AND QUALITY OF LIFE AFTER CORONARY ARTERY BYPASS GRAFT

Among patients undergoing elective primary coronary artery bypass graft, the principal objective of this randomized trial is to compare the efficacy of two strategies of intra-operative hemodynamic management during CPB in preventing peri-operative cardiac, cognitive and neurologic morbidity and mortality and post operative deterioration in the patients' quality of life.